University of Michigan O'Brien Kidney Translational Resource Center (MKTC)

Data Analytic Services Core (DASC).
The continuing need of kidney researchers to mine and extract pertinent knowledge from multi-scalar data sets has necessitated a new Data Analytic Services Core (DASC). DASC will support the investigators by assembling large-scale data sets derived from the clinical cohort studies and trials, from model system studies from the renal research community at large. The key objectives of the DASC will be to empower investigators to independently mine multi-scale data sets, specifically to:
Understand kidney development and injury in global molecular terms in human disease and models;
Define molecular and clinical markers of diagnosis and progression;
Identify critical pathways for therapeutic attack;
Identify patient populations for focused clinical trials;
Perform longitudinal analysis of multi-scale data linking molecular and phenotypic data;
Identify subjects at risk of disease or disease progression; and
Link specific cohorts with background health systems data to permit risk factor evaluation, prediction modeling, and outcomes analyses among those not recruited/sampled in specific cohort studies.
The data set(s) hosted by the DASC will span the full translational research pipeline from preclinical kidney disease model system studies to the human cohort data sets derived. This data will be loaded into DASC-hosted data mining and sharing platforms which have been developed to enable integration of multi-scale data sets to be mined, analyzed, and shared by research base investigators. The data mining and analytic interfaces to interrogate genetic, molecular, histological, or clinical features of interest have been specifically developed towards the needs of the renal researcher

Public health relevance
Data Analytic Services Core Chronic kidney disease (CKD) and Acute Kidney Injury (AKI) remain a major health problem that causes substantial disability and premature death. The University of Michigan George M. O'Brien Kidney Translational Resource Center will provide researchers the opportunity to utilize advanced technologies by providing the necessary infrastructure and tools to improve care of patients with AKI and CKD. Through its research cores, enrichment activities, and community outreach, it will serve as a national resource for enabling new discoveries and enhance scientific progress supporting cutting-edge basic, clinical and translational kidney research.